Epileptic Electrophysiological Brain Networks Modeling with Partially Observable Brain Regions

Project Summary
Epilepsy is one of the most common neurological disorders, affecting 50 million people worldwide
of all ages. Seizures in up to one third of epilepsy patients are drug refractory, where surgery offers
a necessary means to resect epileptogenic regions (EZs). However, the outcomes of epilepsy
surgery may often be suboptimal as on average approximately 50% of patients are still not seizure
free after surgery, mainly due to the EZs cannot be accurately localized.
Traditionally, the EZ is clinically determined by using ictal intracranial electroencephalography
(iEEG) recordings, which are invasive, and can only cover partial brain regions, and with a waiting
period of days to weeks for seizure to occur. In more recent years, it has been recognized by
researchers that seizures arise from a coordinated activity across large scale epileptic networks,
thus characterizing the connections among the involved epilepsy regions is profound to understand
the transmission pathways of epileptic brain network and epileptogenic foci. However, the current
ESI frameworks are insufficient to tackle the changes. Firstly, iEEG electrodes can only record
from partial brain regions, and it is infeasible to record the whole brain intracranial data due to its
invasive nature, and secondly, the existing ESI frameworks suffer from very low accuracy when
it comes to the estimation of whole brain electrophysiological networks.
In this project, we aim to develop a unified paradigm using a simultaneous multimodal
measurement of scalp EEG and iEEG signals to estimate the electrophysiological networks of the
whole brain, thus enabling the characterization of seizure onset zones (SOZ) and its key
transmission pathways from the level of whole brain source space. We aim to bridge the gap
between the less accurate whole brain network reconstruction using source localization with scalp
EEG and the more accurate but regional brain networks constructed from iEEG by using a
principled machine learning framework and letting the partially observable brain signals to “semi-
supervise” the whole brain networks estimation process. We term this new paradigm of source
imaging as “electrophysiological networks imaging” (ENI) in contrast to the traditional
electrophysiological source imaging (ESI). The proposed framework will enable delineation of
brain regions involved in seizure generation and propagation at the whole brain scale and improve
understanding of different epilepsy biomarkers from a network perspective and their values in the
pre-surgery decision making and surgical outcomes.

Public health relevance
Project Narrative Epilepsy is one of the most common neurological disorders and at least 3.4 million people in the U.S. live with seizures, with one third patients being drug-resistant and 50% still having persistent epilepsy after surgery. This project aims to develop an Electrophysiological Network Imaging framework to characterize the seizure onset zones and propagation pathways by an integration of scalp EEG and intracranial EEG to estimate the whole brain electrophysiological networks, based on a principled inference framework with the help of partially observable information from iEEG. The proposed framework can delineate the seizure onset zone and seizure propagation pathways, thus providing an improved epileptogenic zone identification accuracy and a reduced hospitalization time and risk for epilepsy patients.